Human Atherogenesis with Underlying Dysfunctional HDL-Free Cholesterol

Atherosclerotic cardiovascular disease (ASCVD) and plasma high-density lipoprotein cholesterol (HDL-C) are
negatively correlated. One model assigns this correlation to the role of HDL as an acceptor of free cholesterol
(FC) transfer from arterial-wall macrophages (FC efflux), and in some studies, FC efflux better predicted
ASCVD than HDL-C concentration. However, interventions that increase plasma HDL failed to reduce ASCVD,
and, paradoxically, several studies revealed higher ASCVD mortality among patients with very high HDL. The
source of this paradox is unknown, appropriate therapies have not been formulated, and in this context, the
role of the reverse process, HDL-FC influx, which may be supported by excess HDL-FC, is unknown. Mice
deficient in the HDL-receptor, Scarb1-/- mice, are a robust model of the human high-HDL phenotype.
Compared to wild-type mice, Scarb1-/- mice are more athero-susceptible and have higher plasma levels of HDL
that is more FC-rich. This produces a state of high HDL-FC bioavailability, which we express as an index: HDL-
FCBI = HDL particle number (HDL-P) x mol% HDL-FC. This conceptually new metric was first reported by this
study team, which reported that HDL-FCBI increases as wild-type mice < human << Scarb1-/- mice and that
more FC transfers from HDL from Scarb1-/- vs. wild-type mice to macrophages. Thus, we hypothesize that
similar mechanisms underlie ASCVD among humans with very high plasma HDL-C. Our goal is to compare
patients with positive (CACS>0) and negative (CACS=0) coronary artery calcium scores respectively assigned
as ASCVD and non-ASCVD in three subgroups—those with high (HH), intermediate (IH), or optimal (OH)
plasma HDL-C concentrations—and test whether ASCVD is associated with a high HDL-FCBI. According to
our hypothesis, a) HDL-FCBI will be higher among HH vs. OH patients and among ASCVD vs. non-ASCVD
patients, especially those with high plasma HDL-C, and b) the magnitude of FC transfer from HDL from
ASCVD patients to macrophages will be greater than that from HDL from non-ASCVD patients, again
especially among ASCVD patients with high plasma HDL-C. This hypothesis is supported by studies of
Scarb1-/- mice in which a component of HDL-FCBI is reduced and with it, ASCVD—reducing HDL-P with
probucol or mol% HDL-FC by increased FC esterification suppressed ASCVD. Comparison of CACS vs. HDL-
FCBI of all three groups will reveal a non-linear functional relationship.
Traditionally, physicians have measured HDL and LDL in terms of their total cholesterol content. These
measures have had good but imperfect predictive value, mainly because the two components of TC, FC and
cholesteryl esters, have distinct metabolic itineraries that may differentially contribute to ASCVD. Validation of
the study-hypotheses in humans would provide a compelling rationale for measuring plasma lipoprotein FC as
an ASCVD diagnostic and for the formulation of therapies that reduce plasma- and especially HDL-FC.

Public health relevance
The occurrence of increased cardiovascular-disease mortality among patients with very high plasma concentrations of high-density lipoproteins (HDL), the so-called “good cholesterol,” is a paradox for which underlying mechanisms are unknown. HDL is richer in free cholesterol (FC) in animal models of this disorder than in normal animals, so we will test in humans the hypothesis that, compared to normal patients, those with high HDL concentrations and cardiovascular disease have HDL that is richer in FC that rapidly transfers to macrophages, a key cell type in the development of cardiovascular disease. Validation of our hypothesis would provide a compelling rationale for the validation of diagnostics that quantify HDL-FC levels and for the development of therapeutic inhibitors of HDL-to-macrophage FC transfer.